Study DNA methylation changes in brain aging and rapamycin treatment

DESCRIPTION (provided by applicant): Age is the major risk factor for neurocognitive decline and dementia. Preventing and treating age-associated brain disorders will require elucidating the processes and mechanisms underlying normal brain aging and developing interventions that target such mechanisms. This project is based on the hypothesis that rapamycin retards brain aging by correcting age- associated aberrant DNA methylation regulation in the brain. The project tests one unique prediction of this hypothesis in aged mice treated with rapamycin compared with controls: Changes with age will be retarded by rapamycin in DNA methylations and the DNA methylation regulated genes important to synaptic and cognitive function in brain.

Public health relevance
PUBLIC HEALTH RELEVANCE: There is an increasing incidence of age-related neurodegenerative disorders such as Alzheimer's disease and a lack of effective therapies to either block and/or reverse the progression of these disorders. A deeper understanding of the epigenetic mechanisms such as DNA methylation underlying normal brain aging, and rapamycin treatment to ameliorate cognitive decline, is of great public health importance and is the focus of this work.